18th South Central Medical Mycology Annual Conference, 2021

Abstract
Funds are being requested to provide partial support for the 18th Annual South Central Medical Mycology
(SCMM) meeting to be held in the hotel Menger at San Antonio, TX on November 19-20, 2021. SCMM prides
itself on bringing a critical mass of medical mycology researchers together from the south central region of the
United States to share the latest research being conducted in the various labs, provide opportunities for
collaboration, and promote the development of junior trainees in participating laboratories. The meeting site
rotates between university-centered locations in the south central region where fungal-centric laboratories are
located. Principal Investigators and students/postdocs from ~15 laboratories usually attend annually (including
laboratories in the host city). In total there are upwards of 20 laboratories that have attended one or more of
the meetings depending on the location site. Hence, a strong and growing critical mass of medical mycologists
have supported this meeting and led to its longevity and significance over the past 19 years. Although the
meeting format has evolved over the years, the current format has focused on oral presentations by trainees
regarding their most exciting and impactful unpublished data. The small group setting provides a welcoming
environment that has been successful in promoting discussion and constructive feedback for trainees. Hence,
the primary objectives of the meeting are to 1) bring regionally-based medical mycologists together to share
research, initiate collaborations, and provide a venue for trainees to present their latest work, and 2) promote
the development of young/junior scientists as a mentoring tool to facilitate their transition into academic
scientists or their chosen career path. The funding requested is for trainee travel awards (n=10) and to cover
travel costs for the keynote speaker.

Public health relevance
Narrative The South Central Medical Mycology (SCMM) meeting is unique in that it is focused primarily on presentations of unpublished work by trainees including graduate students and postdoctoral fellows of all levels from laboratories of successful Principal Investigators (PIs) in the region. The SCMM also provides strong developmental groundwork for the trainees in the medically important mycology field who attend as all presentations are oral, followed by a question/answer session, and later, informal discussions with presenters. Hence, the impact and significance of the meeting to the public health has and continues to be high.